Targeting CDK4/6 as an interception strategy for intraductal papillary mucinous neoplasia

ABSTRACT
Intraductal papillary mucinous neoplasms (IPMN) are common cystic neoplasms of the pancreas that may
progress to pancreatic ductal adenocarcinoma (PDAC), a lethal disease with a current 5-year survival rate of
12%. The management for patients with IPMN high-risk features, mandates surgical resection in patients fit for
surgery. While surgical resection is curative for some individuals, pancreatectomy carries significant risk of
postoperative morbidity, and IPMNs reoccur in 30 – 60% of patients with invasive disease. Strikingly, 4-5% of
patients with IPMN biopsies containing pathological features that reveal high grade dysplasia will be diagnosed
with invasive PDAC within 5 years of their pancreatectomy. As such, identifying effective interception strategies
for IPMN is a significant unmet need. Here we have based our research approach on reverse translational
experiments where we have identified that the presence of co-oncogenic driver mutations in KRAS and GNAS
renders multiple cancer types originating from different organs susceptible to CDK4/6 inhibition in patients. As
~70% of IPMN tumors contain KRAS and GNAS co-mutation, here we will determine the impact of CDK4/6
inhibition on IPMN tumor progression in genetically modified mice and PDX models of IPMN, where we can
tightly regulate the timing, dosing, tumor genetics, as well as analyze tumor responses in pre-clinical models. In
addition to studying endpoints of tumor progression and survival, we will determine the effects of CDK4/6
inhibition on the tumor microenvironment of IPMN. The results of these studies will provide key translational
data that will propel future human clinical trials.

Public health relevance
PROJECT NARRATIVE Intraductal papillary mucinous neoplasms (IPMN) account for roughly 15% of precursor lesions of pancreatic ductal adenocarcinoma (PDAC). IPMN fluid filled cystic nodules are often identified incidentally with current imaging platforms used for diagnostics such as MRI and endoscopic ultrasound, thus are a clinically identifiable patient group. Based on reverse-translational data, the proposed work aims to determine the efficacy of FDA approved CDK4/6 inhibitors in murine and human models of IPMN, as well as the changes occurring to the tumor microenvironment during pancreatic cancer interception using CDK4/6 inhibition.